Long-term durability of DENV-specific immunity after vaccination in a dengue-endemic population

Abstract
The goal of this FOA is “to improve our understanding of how vaccines against infectious agents
lead to durable protective immunity.” This project seeks to address this objective through a detailed
characterization of immune responses in the early phase post-vaccination to identify components that
distinguish durable from non-durable responses to vaccination with a live attenuated vaccine against
dengue virus (DENV). To date, a single dengue vaccine (CYD-TDV) has reached licensure and others
have shown promising efficacy data, but there remain important gaps in the safety and efficacy of these
vaccines, particularly around the issue of the durability of protective immunity. This project leverages
blood samples available from dengue vaccine trials, in particular a longitudinal study of participants from
a phase III trial of CYD-TDV that has been ongoing since 2011. The project addresses the overall
hypothesis that functional, transcriptomic, and epigenetic profiles of DENV-specific T and B lymphocytes
early post-vaccination predict the establishment of long-lasting DENV-specific serologic immunity
through the following Specific Aims: 1) Identify T and B cell functional responses to DENV associated
with the long-term persistence of binding and neutralizing antibodies after receipt of CYD-TDV; 2) Identify
gene expression and epigenetic profile(s) in DENV-specific T and B lymphocytes associated with the
persistence of antibodies after receipt of CYD-TDV; and 3) Validate the immunological signature of
durable antibody responses in recipients of CYD-TDV and compare this signature to other dengue
vaccines and to natural and experimental DENV infection.

Public health relevance
Project Narrative This project will apply comprehensive flow cytometry and single-cell RNA sequencing to identify functional, transcriptomic, and epigenomic profiles in individual dengue virus (DENV)-specific T and B lymphocytes present early after immunization that are predictive of the durability of DENV-specific serological immunity over a >8-year follow-up period.